Processing of Apoptotic Cell-Derived Cargo by Macrophages Continues Efferocytosis and Drives Atherosclerosis Regression

PROJECT SUMMARY/ABSTRACT Atherosclerotic cardiovascular disease (CVD) is the leading cause of death in the industrialized world. Most atherosclerotic plaques are clinically silent; however, a subset can lead to myocardial infarction, stroke, or sudden death. Atheromas that are linked to clinical events are characterized by large necrotic cores, which result from the defective clearance of apoptotic cells (ACs). When functioning normally, clearance of ACs, termed “efferocytosis”, resolves inflammation. Therefore, enhancing efferocytosis in advanced lesions may stabilize rupture-prone plaques and reduce clinical events. While the mechanisms that lead to phagocytosis of one AC have been well-defined, individual macrophages (M?s) must engulf many ACs, termed “continued efferocytosis”, in vivo. Accordingly, two critical, unanswered questions are (a) how do M?s process the cargo derived from degrading an AC, and (b) what mechanisms are in place that cue M?s that have previously ingested an AC to internalize a subsequent AC. Therefore, the overall objective of this proposal is to understand the signaling and metabolic pathways that enable the continued clearance of ACs and to harness these pathways towards a novel treatment strategy. This proposal tests two new pathways critical for continued efferocytosis. In the first pathway, M?s metabolize AC-derived arginine into putrescine, through the sequential action of arginase 1 (Arg1) and ornithine decarboxylase (ODC), to remodel the actin cytoskeleton. In the second pathway, M?s respond to the overabundance of AC-derived nutrients by stimulating the nutrient sensor mTORC1 to recycle vesicles to the cell surface and supply the developing phagosome with plasma membrane. Aim 1 will explore the hypothesis that AC-derived arginine is metabolized into putrescine and examine the mechanisms by which putrescine regulates cytoskeletal remodeling. Aim 2 will test the hypothesis and investigate the mechanisms therein, that the putrescine-synthesizing enzymes Arg1 and ODC drive atherosclerosis regression and inflammation resolution. Aim 3 will explore the hypothesis that SLC38A9 senses AC-derived arginine and cholesterol to activate mTORC1 and identify the mechanisms that drive the internalization of a second AC. This research will be accomplished in the setting of a comprehensive career development program designed to provide the candidate with the skills needed to become an independent scientist in cardiovascular research. During the K99/Mentored phase of the award, the applicant will continue to gain expertise in molecular, cellular, and biochemical approaches to study atherosclerosis regression from a mechanistic standpoint. An advisory committee of established scientists/mentors in the fields of atherosclerosis, macrophage function, inflammation resolution, and translational science will guide the candidate in his transition to scientific independence over the course of the award period.

Public health relevance
PROJECT NARRATIVE Atherosclerotic cardiovascular disease is the leading cause of death in the industrialized world. Clinically-relevant plaques are characterized by a large necrotic core, resulting from the defective clearance of apoptotic cells. This proposal aims to explore the signaling and metabolic pathways that enable the continued clearance of apoptotic cells by macrophages, which should reveal new approaches to stabilize rupture-prone plaques.